In situ structures of SARS-CoV-2 Spike fusion intermediates and Spike-antibody-Fc receptor complexes

PROJECT SUMMARY
Variants of SARS-CoV-2 continue to emerge with mutations in Spike that cause increased resistance to
monoclonal antibodies and vaccines. These variants underscore the need for more universal antiviral
approaches, such as targeting conserved regions in Spike and utilizing more broadly reactive Fc-mediated
immune functions. Spike contains highly conserved regions in the S2 domain which may be an attractive target
for the design of inhibitors. These regions are thought to be exposed when S2 undergoes large conformational
changes to mediate membrane fusion and viral entry. Molecular dynamics simulations have modelled this
process in silico, structural detail is lacking in situ which leaves a gap in our understanding of viral entry and may
preclude further inhibitor development. Spike can also be targeted by antibody Fc effector functions such as
antibody-dependent cellular cytotoxicity. Antibody Fc effector functions against Spike have been shown to be
more broadly reactive and longer lasting in patients than virus neutralization. Eliciting stronger Fc-mediated
immunity is therefore an important consideration in the design of immunogens and antibody therapies. However,
Spike-IgG-Fc receptor complexes in native membranes have never been described at the molecular level which
makes it difficult to define the structural correlates of Fc effector functions. The overarching goal of this proposal
is to investigate the conserved Spike S2 domain and its inhibition during membrane fusion and Fc effector
functions targeting Spike within native membranes. I hypothesize that Spike-host receptor interactions in native
membranes are key vulnerabilities that can be targeted through antibody Fc effector functions and inhibitors to
the conserved S2 domain. To test this hypothesis, I have developed a system to observe Spike-host receptor
interactions in situ by presenting them on opposing virus-like particles (VLPs) and monitoring their interactions
with cryo-electron tomography (cryoET). In Aim 1, I will investigate the conserved S2 domain during membrane
fusion by arresting the membrane fusion process at different stages. My preliminary data show how temperature
arrests and inhibitors stabilize prefusion Spike and S2 intermediate structures in situ to provide a unique window
into viral entry. Further, my data suggests that multivalent inhibitor cross-linking of S2 intermediates may be a
key antiviral strategy to disrupt the cooperative arrangements of S2 that orchestrate membrane fusion. In Aim 2,
I will identify structural correlates of Fc effector functions by determining how antibody Fc accessibility and the
ability to cluster Spikes and Fc receptors on membranes affect Spike-antibody-Fc receptor complex formation.
In preliminary data, I have visualized these complexes in situ in unprecedented molecular detail using cryoET. I
have also developed a method to directly visualize and quantify antibody-mediated Spike clustering on virion
membranes. Collectively, these data will provide detailed molecular insight into Spike-mediated membrane
fusion and Fc-mediated effector functions against SARS-CoV-2 to guide the development of pan-coronavirus
inhibitors and immunogens.

Public health relevance
PROJECT NARRATIVE The reduced efficacy of vaccines and monoclonal antibodies against SARS-CoV-2 variants of concern underscores the need for more universal antiviral approaches. I will investigate the structure and dynamics of highly conserved regions within Spike, the main target of neutralizing antibodies, and identify structural correlates of broadly reactive antibody Fc effector functions. This work will reveal key vulnerabilities of the Spike protein to inform the design of cross- reactive antibody therapies, Spike inhibitors, and vaccines.